Rapid and robust assay for measurement of in vivo activity of chromatin-interacting proteins

PROJECT SUMMARY
The activity of chromatin-associating proteins (CAPs) is fundamental to regulation of gene expression.
Elucidating CAP activity is central to understanding the regulatory mechanisms that drive cell biology, both in
the context of health and disease, and to guide development of novel therapeutics. However, this work is not
straightforward, as CAP activity is regulated by multiple factors including post-translational modifications and
subcellular localization. Thus, assays to study CAP activity must specifically detect CAPs in their active form
(i.e., bound to chromatin, directly or in complex). Genomic mapping assays can provide detailed information on
CAP engagement and localization; however, these assays are inaccessible to a majority of researchers and
unsuitable for large-scale, high-throughput studies due to a high barrier of entry associated with cost, complexity,
equipment, and data analysis. Other existing assays to study CAPs capture total cellular abundance (e.g.,
EMSAs, ELISAs, IHC) or transcript levels (e.g., qPCR, RNA-seq), and do not specifically quantify CAPs actually
associated with chromatin in vivo. Thus, there is a field need for a high-throughput, low-cost assay that is
accessible to all researchers, and can inform CAP activity via quantification of in vivo engagement on chromatin.
Market availability of such an assay would be transformative for biomedical research by providing convenient
access to study the role and response of CAP in gene regulatory programs, including analysis of drug mechanism
of action and immune stimulus responses, as well as for high-throughput drug screening.
Here, EpiCypher will develop QuantiCAPTM, a breakthrough assay that will enable the study of in vivo
activity of CAPs. The innovation of this proposal is the development of a targeted approach to directly quantify
the total amount of CAP-bound chromatin in cells. Our approach leverages an in situ immunotargeting strategy
to excise CAP-bound chromatin combined with highly sensitive detection by a fluorescent DNA stain. Overall,
this platform will provide the first quantitative, low-cost, and scalable approach to leverage analysis of CAPs for
biomedical research. In this Direct to Phase II research program, we are highlighting development of the platform
to study transcription factors (TFs) and chromatin reader proteins, though our platform will be broadly applicable
for the study of any CAP. In Phase I, we developed an automated QuantiCAP workflow, demonstrating feasibility
for the assay to quantify changes in a CAP following drug treatment, and identified assay conditions to further
improve sensitivity. In Phase II, we will extend QuantiCAP assay development to cover five (5) high value targets
using both manual and automated workflows, including genomics validation. We will validate our assays across
diverse primary immune cells and stimuli, then determine cell input thresholds, a robust normalization strategy,
and quantitative assay parameters. Finally, we will prepare for marketing and commercialization by developing
a QuantiCAP beta kit and applying the automated assay to perform high-impact drug development studies.

Public health relevance
PROJECT NARRATIVE Studying the activity of chromatin-associating proteins (CAPs) is central to understanding the regulatory mechanisms that control gene expression. However, existing assays to study CAPs either require expensive sequencing and complex data analysis or do not specifically capture chromatin-bound CAPs. Here, EpiCypher is developing a novel, sequencing-free assay that will make accessible the study of global in vivo activity of CAPs.